Impact of circulating levels of endocrine disrupting toxicants on cognition, brain activity and Alzheimer's disease biomarkers across the menopausal transition

Project Summary
Alzheimer’s disease (AD) is a progressive neurodegenerative disorder that severely hinders quality of life. It is
the leading cause of dementia in the elderly, and disproportionately affects women. Not only are women more
likely to be diagnosed with AD, but when they are, they show steeper rates of episodic memory decline, the
hallmark clinical symptom of AD, and higher levels of brain-based pathology, both in life and postmortem. By
capitalizing upon recent technical advancements in toxicological and steroid hormone assay techniques, this
project will test whether, when and how exposure to endocrine disrupting persistent organic pollutants during
the menopausal transition modifies cognition, brain activity and blood-based AD biomarkers. The results of this
study will have important implications for our understanding of potentially modifiable factors that impart
increased risk for AD, as well as the causes and consequences of sex-based disparities in this devastating
neurological disease.

Public health relevance
Project Narrative Women make up two-thirds of Alzheimer’s disease (AD) cases in the US. This project investigates how exposure to endocrine disturbing persistent organic pollutants (POPs) across the menopausal transition impacts cognition, brain function and plasma-based AD biomarkers. The overarching goal is to determine whether these toxicants, which are present in a wide range of industrial products, represent a potentially modifiable risk factor for AD that have differential impacts on health in men and women.